Proteomic Profiling of Cardiac Dysfunction in the MACS-WIHS Combined Cohort Study

Abstract
Fund Year 2023 OAR Strategic Funds are requested to perform high-throughput proteomic
measurements to investigate the protein signatures of cardiac dysfunction in MWCCS.
Previously collected blood specimens in participants who completed baseline echocardiography
in MACS Visits 67-71 (n=1195) and WIHS Visits 44-50 (n=1655) will be used to measure
proteomics in order to permit discovery of protein markers. Genotypic data in MACS and WIHS
will be leveraged to conduct Mendelian randomization analysis using protein quantitative trait
loci, allowing causal inference and selection of protein targets for pharmacotherapy. This
supplement will support HIV/AIDS research corresponding to the following NIH high-priority
AIDS-designated topics: (1) HIV-associated comorbidities; (2) cross-cutting areas involving
clinical translational research, cardiovascular disease, proteomics, multi-omics, and health
disparities; and (3) training of the next generation of HIV investigators in omics and
comorbidities research.

Public health relevance
Project Narrative People living with HIV and those at risk for HIV have high rates of heart disease, but the reasons for this are not fully understood. We plan to measure thousands of proteins in blood from study participants with and without HIV to study their relationship to abnormal heart function measured by ultrasound. By also using information from participants’ genes, we may identify new causes of heart disease that could lead to better treatments for people with and without HIV.